IND enabling CMC/safety/toxicology studies, submission of IND and pilot Phase 1 clinical trial with PV-1950R vaccine for Lewy Body Dementia (LBD)

Project Summary
Lewy Body Dementia (LBD) affects 1.4 million people in the United States and is the second most prevalent type
of dementia in the country. LBD includes individuals who initially present with a cognitive-behavioral disorder
(dementia with Lewy bodies) and those who initially present with a movement disorder (Parkinson's disease
dementia). LBD is even more expensive than Alzheimer's disease, as dementia occurs at an earlier age of
disease onset. It progresses faster and leads to greater disability and caregiver burden. Currently, there are no
medications that the FDA has approved to treat LBD, and only a limited number of medications are being tested
in clinical trials, creating a significant gap in available treatments for patients and their families. The key pathology
in LBD is the aggregation of the presynaptic protein, αSyn, in neuronal cell bodies (Lewy bodies), neuronal
processes (Lewy neurites), and synapses affecting the neocortex, limbic structures, and peripheral autonomic
neurons. Immunotherapy is being explored as a promising treatment option for LBD, as antibodies can prevent
the accumulation or possibly inhibit the spreading of pathological aggregated αSyn that contribute to the disease.
Of particular interest to this hypothesis is that a prodromal state of LBD exists in the form of rapid eye movement
sleep behavior disorder (RBD), associated with brainstem and peripheral αSyn aggregates preceding LBD onset
by more than two decades, making it an ideal target for an immunogenic preventive vaccine. We developed a
universal platform technology in the last decade, especially for neurodegenerative disorders, and manufactured
two MultiTEP-based cGMP-grade vaccines targeting pathological Aβ and tau. One of these vaccines is currently
in a Phase 1 trial with early AD individuals, and another will be used for a Phase 1 trial with cognitively unimpaired
participants. More recently, using MultiTEP platform technology, we also developed four vaccines targeting
different regions of pathological αSyn and tested their immunogenicity and efficacy in an LBD mouse model. The
most immunogenic and preclinically effective vaccine, PV-1950R targeting three B-cell epitopes of pathological
αSyn simultaneously, has been selected to move forward for IND-enabling studies. Our preliminary results show
that this vaccine induces high titers of αSyn antibodies in the LBD mouse model and reduces total and proteinase
K resistant αSyn, neurodegeneration, and brain inflammation. Accordingly, in this proposal, we suggest
conducting pre-clinical IND-enabling studies and a pilot Phase 1 trial on this vaccine targeting three B cell
epitopes of pathological αSyn. Studies will include (i) manufacturing of engineering-run recombinant protein that
is, according to FDA guidance, sufficient for safety/toxicology studies; (ii) completing safety/toxicology studies in
the LBD mouse model; (iii) completing immunogenicity and overall safety studies in non-human primates; (iv)
manufacturing cGMP PV-1950R/A bulk drug substance and fill/finished drug product, (iv) submit and obtain IND,
and (v) conduct pilot Phase 1 clinical trial with healthy volunteers (phase 1a) and with patients with RBD (Phase
1b) who are at the risk of LBD.

Public health relevance
Project Narrative LBD, also known as Alzheimer's Disease Related Disorder (ADRD), is the second most common cause of dementia after AD affecting approximately 1.4 million Americans, with no FDA-approved medications to treat LBD and few medications in clinical trials, leaving a great unmet need for patients and their families. Recently we developed the PV-1950R/A vaccine based on a MultiTEP platform technology that is highly immunogenic in mice, rabbits, and monkeys and demonstrated the efficacy in the αSyn D line mouse model of LBD. In this U01 project, we propose to manufacture the cGMP adjuvanted vaccine, PV-1950R/A, complete IND-enabling safety/toxicology studies in LBD mouse model and non-human primates, submit and obtain all of the necessary regulatory documents for an FDA-approved investigational new drug (IND) and conduct pilot phase 1 trial in healthy individuals (Phase 1a) and individuals with patients with rapid eye movement sleep behavior disorder (RBD) who are at the risk of LBD (Phase 1b).